Modifiable Drivers of Expansion and Malignant Transformation from Clonal Hematopoiesis

Project Summary/Abstract
Clonal hematopoiesis (CH) is an age-associated pre-malignant condition in which the progeny of hematopoietic
stem and progenitor cells (HSPCs) with somatic mutations in about 20 genes dominate production of the
peripheral blood. While CH can persist without apparent health consequences for decades, it is associated with
increased risk for hematologic malignancies as well as all-cause mortality. Extrinsic conditions that favor
particular clones may separate asymptomatic CH carriers from those that progress to disease; yet, the specific
risk factors that can be modified to influence CH and its sequelae are largely unknown. The overall goal of this
Program, with three interactive Projects and two Cores, is to identify modifiable risk factors of CH-associated
HSPC expansion and subsequent malignant transformation, with a long-term view toward developing cancer
prevention strategies. A major feature of our Program is the use of novel mouse models to mimic CH and test
mechanisms that drive clone expansion and malignancy. In addition, our Program harnesses data from the
exceptional Atherosclerosis Risk in Communities (ARIC) study – which has followed more than 9,500 diverse
participants (27% Black, 55% female) over 30 years – to evaluate CH and malignancy risk in older adults. Project
1 models CH in mice, with an emphasis on HSPCs bearing mutations in epigenetic regulators (particularly
Dnmt3a and Tet2), to determine how inflammatory stress and metabolic changes promote expansion, including
cooperation between clones, and malignant transformation. Project 2 focuses on CH with DNA Damage
Response (DDR)-associated gene mutations, and how exposure to genotoxic stress from chemotherapy and
smoking enables clonal dominance and malignant transformation in mice. Both Projects 1 and 2 explore potential
interventions to suppress clone expansion. Project 3 analyzes the contribution of inflammation and DNA
damaging exposures to clonal expansion and malignant transformation in the ARIC cohort, capitalizing on
clinical, proteomic, methylation, whole exome sequencing, and metabolomic data already available. Project 3
will also perform single cell sequencing to determine changes in CH clonal contribution over time, including clonal
interactions, and the evolution to malignancy in the context of external stressors. The Projects are highly
interactive, with Projects 1 and 2 iteratively testing the causal and mechanistic influence of risk factors nominated
by preliminary studies and by Project 3, and Project 3 performing additional analyses to validate findings
generated by Projects 1 and 2. Projects 1 and 2 are mutually enhanced by shared approaches and data.
Together, all Projects will deconvolute the role of risk factors to CH and malignancy. The Program is supported
by a Single Cell Sequencing and Bioinformatics Core and an Administrative Core. By focusing on modifiable risk
factors, we can stratify the risk of hematologic malignancy to inform clinical guidance of individuals with CH. Our
expert team combines clinicians and scientists with long track records of successful collaboration. Together we
will address this critical problem for human health and longevity.

Public health relevance
Project Narrative Somatic mutations and modifiable factors interact to drive the development of clonal hematopoiesis (CH) and its transformation to hematologic malignancy. How to stratify risk for patients remains a significant open question, as not all patients with dominant clones go on to develop CH, and not all those with CH go on to develop cancer. In three synergistic mouse and human projects, our Program will identify how extrinsic stressors interact with specific genetic mutations to influence the clonal expansion and malignant transformation of hematopoietic stem and progenitor cell clones in order to inform clinical guidance of individuals with CH.